Etimizol for reversal of Xylazine-fentanyl respiratory depression

PROJECT SUMMARY / ABSTRACT
Increasing use of xylazine, most often in combination with other drugs such as fentanyl, is a rapidly growing
threat to human health in the United States. Patients presenting with xylazine intoxication may have central
nervous system depression, hypotension, and bradycardia. Naloxone can reverse opioid-induced respiratory
depression but does not reverse the effects of xylazine. There is no xylazine-reversal agent currently approved
for use in humans. One may also need to consider that opioid agonists may be combined not only with xylazine
but with other drugs that cause respiratory depression alone or in combination. Therefore, there is an urgent
need to identify and rapidly introduce into clinical practice respiratory stimulant agents with a non-opioid
mechanism of action. Synventa identified an old respiratory stimulant drug, etimizol, that was developed about
60 years ago but was never marketed outside Eastern Europe. Ability of etimizol to reverse opioid-induced
respiratory depression was established in rabbits in 1960s and was recently confirmed and extended by the
Synventa team using models of morphine-, phenobarbital- and gamma-hydroxybutyrate-induced respiratory
depression in laboratory rodents via non-opioid mechanisms. These studies were: i) conducted under
exploratory study rigor standards (limited sample size, male animals only, no pre-specified exclusion criteria
or analysis), and ii) have not established the ability of etimizol (or its main metabolite) to reverse respiratory
suppression induced by xylazine alone or in combination with opioid agonists.
In this regard, and in line with RFA-DA-23-021, the current application proposes preclinical proof of concept
studies to confirm the ability of ethimizol to reverse respiratory depression induced by opioid-xylazine
combination.
In Phase 1, we will (Aim 1) characterize the ability of xylazine to cause respiratory depression when given
alone or in combination with fentanyl in mice; (Aim 2) deliver confirmatory evidence regarding the ability of
etimizol to reverse respiratory depression induced by opioid-xylazine combination; (Aim 3) evaluate the ability
of etimizol’s main metabolite to reverse respiratory depression induced by opioid-xylazine combination.

Public health relevance
PROJECT NARRATIVE Increasing use of xylazine, most often in combination with other drugs such as fentanyl, is a rapidly growing threat to human health in the United States. Naloxone can reverse opioid-induced respiratory depression but does not reverse the effects of xylazine. There is an urgent need to identify and rapidly introduce into clinical practice respiratory stimulant agents with a non-opioid mechanism of action. Synventa identified an old respiratory stimulant drug, etimizol, that can reverse respiratory depression via non-opioid mechanisms. A team of experienced industry and academic drug hunters, Synventa proposes preclinical proof of concept studies to confirm the ability of etimizol to reverse respiratory depression induced by opioid and non-opioid drugs such as xylazine.